Admin Core

PROJECT SUMMARY: Administrative Core
The Administrative Core of the Washington University School of Medicine (WUSM) Diabetes Research
Center (DRC) provides the structure for effective and efficient operation of the DRC in compliance with NIH
and University guidelines. The Core encompasses the roles of the Director, Co-Director, Associate Directors,
Internal and External Advisory Committees, the Pilot and Feasibility Review Committee, Core Oversight
Committees, and the Program Manager. It contributes to the mission of the DRC by providing Leadership and
Organization, Operational Oversight, and mechanisms that include an Enrichment Program for Promoting
Communications with the Diabetes Community. Information provided in this renewal application strongly
supports the notion that the Administrative Core is responsive to DRC needs and dedicated to promoting
innovative research that is being translated to the care of people with diabetes and related disorders.